Validation of Video Administration of a Modified UDSv3 Cognitive Battery

Project Summary
This multi-site R01 aims to validate video-administered cognitive assessments for use by the
Alzheimer’s Disease Research Centers (ADRCs) and other research programs whose activities have been
interrupted by the COVID-19 pandemic, as well as for use in future initiatives when remote testing will enhance
achievement of scientific goals. While face-to-face administration is the gold standard for cognitive
assessments, conditions often arise that prevent participants from attending in-person visits. These barriers
include transportation challenges, limited mobility, and financial hardship. There is also evidence that
underserved populations, including rural populations and racial/ethnic minorities, are less likely to enroll in
studies that require travel to an academic medical center for face-to-face testing. The proposed study will
address these challenges by utilizing a video-adapted battery incorporating the Uniform Data Set version 3
(UDSv3) measures with additional measures that may serve as alternatives for UDSv3 measures not
adaptable to video administration. We propose to fully validate these assessment tools for remote
administration in partnership with the NIA and the National Alzheimer’s Coordinating Center (NACC), and
carried out by a consortium of 12 ADRCs. Pilot data was gathered from 88 Wake Forest ADRC participants,
deemed by in-person testing and adjudication to have normal cognition, MCI, or dementia, who were tested
either by phone or video. Data show high participant ratings of tolerability, feasibility, and preference for video
versus telephone assessment. There is also high concordance between video-administered and in-
person test scores. Based on this collective data, we plan to fully validate a video-version of the UDSv3
battery in a range of cognitively, ethnically, and geographically diverse participants. We propose to administer
remote video cognitive assessments, paired alongside annual in-person cognitive assessments, in
counterbalanced order, to 500 existing participants from 12 ADRCs utilizing a computer tablet device, including
those previously adjudicated as having normal cognition, MCI and dementia. Participants’ ratings of
satisfaction with test condition and preference of test modality will be obtained, in addition
to the psychometric characteristics of the video battery relative to face-to-face administration, including
concurrent validity, and estimates of relative bias overall and across important subgroups (age, ethnicity,
cognitive status) and mode of administration of individual tests. Concordance between adjudication
outcomes will also be examined to assess the ability of the battery to distinguish normal cognition, MCI and
dementia. We will assess the sensitivity of the video battery to detect longitudinal change in cognition in ADRC
participants by repeating counterbalanced, in-person and remote assessments 2 years following initial
evaluation. Completion of this project is critical to the ongoing success of cognitive assessment in the ADRC
network.

Public health relevance
Project Narrative This inter-ADRC project seeks to validate a video-administered cognitive assessment for use by ADRCs whose in-person activities have been interrupted by the COVID-19 pandemic. This assessment battery, which incorporates a core set of the Uniform Data Set version 3 (UDSv3) measures, can also be used in future ADRC initiatives to support recruitment and retention of historically underserved populations who are less likely to travel to a metropolitan medical center for assessment.